ALGORITHM FOR PROCESSING RAW MASS SPECTROMETRIC DATA TO IDENTIFY AND QUANTITATE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. A Lipid Qualitative/Quantitative Analysis (LipidQA) software platform has been developed to identify and quantitate complex lipid molecular species in biological mixtures (16).